Building and Validating Lifelong Self-Management Capacity with Advanced AI: MyMSMentor

PROJECT SUMMARY
In 2018, 51.8% (129 million) of American adults had at least one chronic condition (e.g., diabetes, arthritis). The
total cost of chronic conditions is $3.7 trillion; about 84% of healthcare costs are attributed to chronic condition
treatment. Self-management is critical to reducing clinical and economic burdens. Multiple sclerosis (MS)
is one of the most demanding cases, costing approximately $28 billion for about one million Americans with MS.
However, people with chronic conditions, including people with MS (PwMS), often face challenges in applying
self-care information and partnering with their clinicians over their illness progression to reflect their ever-
changing needs. Unfortunately, the existing self-management interventions and mHealth solutions for PwMS
and other patients do not support self-sustained personalization of self-management through lifelong user
modeling. To address these challenges, we propose MyMSMentor, a Health Action Process Approach (HAPA)-
driven artificial intelligence (AI) agent, to estimate users’ states and provide just-in-time guidance. Overarching
goals are: [i] developing personalized, lifelong self-management support that is contextualized in an individual’s
daily life and available resources; [ii] making MyMSMentor generalizable for the millions of people who need
lifelong self-management of other chronic conditions. The innovation of the study focuses on bridging HAPA,
social-cognitive science, and AI algorithms to build a theory-based intelligent healthcare advising agent that can
support the adoption and maintenance of health behavior. Specific Aims are: (1a) Build MyMSMentor for
proactive patient-centered self-management support; (1b) adopt participatory design to refine and evaluate
MyMSMentor iteratively; (2) validate the feasibility and acceptability of MyMSMentor with PwMS. For Aim-1a, we
will build [i] lifelong comprehensive user modeling by combining the Information Need Model, Known Information
Model, and HAPA status variables and [ii] five function modules (i.e., symptom recording and updating, case
summary generation, note-taking, user model inference module, HAPA-based interactive intervention module).
For Aim-1b, we will collaborate with patient and clinician advisory boards to co-design and evaluate MyMSMentor
iteratively. For Aim-2, 50 PwMS will use MyMSMentor for 30 days. They will use feasibility and acceptance
measures to evaluate MyMSMentor and provide user feedback. The study will make a critical and timely
contribution to establishing a generalizable novel model to bridge big data, artificial intelligence, and social-
cognitive science for precision self-management among people with chronic conditions and support the
National Neurological Conditions Surveillance System to advance data-powered research and healthcare
services.

Public health relevance
PROJECT NARRATIVE About 51.8% (129 million) of American adults had at least one chronic condition, which is attributed to the total direct and indirect cost of $3.7 trillion and demands imperatively patients to self-manage their health across their lifespans. However, most existing self-management interventions and apps do not enable users with chronic health conditions, such as multiple sclerosis (MS), to actively utilize resources, solve problems, develop self- efficacy, and empower decision-making. We will develop and validate MyMSMentor for people with MS, which will be generalizable to other chronic conditions and devices, to maximize their lifelong capacity of self- management.